CYTOSKELETON-MEMBRANE INTERACTIONS

A complete understanding of phenomena such as morphogenesis, wound healing, and viral transformation is contingent upon an understanding of fundamental cell-cell and cell-substrate attachment. At the core of our ignorance about these basic life processes is a lack of knowledge about the molecular details of transmembrane inter-actions between the cytoskeleton and the cell surface. The ameboid stage of the cellular slime mold, Dictyostelium discoideum is easily grown in large quantities, is motile, and exhibits cell-cell as well as cell-substrate attachment. Using D. discoideum as a model for cells in general, I will investigate the interactions between this cell's plasma membrane and its cytoplasmic cytoskeletal proteins. Preliminary work has shown that the cytoskeletal proteins, actin and myosin, are isolated with D. discoideum plasma membranes, that detergent extraction of these membranes results in an actomyosin-containing membrane cytoskeleton (as distinguished from the total cytoskeleton), and that these membranes bind exogenous F-actin if, and only if, the endogenous actin is previously removed. Integral membrane proteins have been implicated as the agents responsible for this binding. The immediate goals are to identify the major proteins in the membrane cytoskeleton and to determine the molecular basis of the attachment of actin to the membrane. I am both developing new approaches to these problems and employing techniques that have been successfully applied to the study of the erythrocyte membrane cytoskeleton. These approaches include electron microscopy; preparation and characterization of inside-out and right-side-out plasma membrane vesicles; purification of integral membrane proteins; transfer labeling with a heterobifunctional, cleavable, crosslinking reagent; and the use of a new, stable, high-capacity F-actin affinity matrix. Of ultimate interest is the characterization of membrane proteins involved in differentiation, motility and cell-cell and cell-substrate interactions.